INTRAVENOUS DOSE-RESPONSE STUDY OF NONEQUILIBRIUM &STEADY STATE GROWTH HORMONE

The invesigators will study the disappearance rates of pure human recombinant GH in normal men of various ages, and subjects with obesity, chronic renal failure, and liver disease.